Regulation of the host immune response to influenza by the checkpoint receptor Tim3

PROJECT SUMMARY
Influenza remains an important cause of morbidity and mortality and current therapies have limited efficacy.
Respiratory failure in influenza results from either prolonged viral replication or lung injury induced by an
over exuberant immune response. It follows that a better understanding of the mechanisms that regulate
the host immune response to IAV could lead to new therapies. Effector CD8+ T cells are responsible for
clearance of influenza A virus (IAV) during primary infection but have also been implicated in immune-
mediated lung injury. Effector CD8+ T cells also give rise to influenza-specific CD8+ tissue resident memory
T cells (Trm), which mediate heterosubtypic immunity, decreasing the severity of subsequent IAV infection.
Thus, the magnitude and quality of the CD8+ T cell response to IAV must be tightly controlled to achieve
viral clearance, limit immune-mediated lung injury and promote the formation of tissue-resident memory.
Dendritic cells (DC) activate naïve T cells in the lymph node to generate an effector CD8+ T cell response,
interact with effector CD8+ T cells within infected lung to promote viral clearance and attenuate
immunopathology and are required for the generation of optimal CD8+ Trm. Thus, DC play a critical role in
regulating both effector CD8+ T cells and in the formation of protective memory. Effector CD8+ T cells are
also regulated by inhibitory (i.e. checkpoint) receptors. T cell immunoglobulin and mucin domain 3 (Tim3)
is an important checkpoint receptor that is induced on activated T cells and constitutively expressed on
DC. Tim3 modulates the immune response to IAV, but it is not known whether it constrains viral clearance
or protects from lung injury. We previously demonstrated Tim3 attenuates effector CD8+ T cell responses
and protects against mortality in a mouse model of IAV. We now have data demonstrating that Tim3
promotes antigen cross presentation by DC – a process critical for generating both effector and tissue
resident memory CD8+ T cells in IAV infection. Our central hypothesis is that Tim3 determines the
balance between viral clearance and lung injury and promotes the formation of CD8+ Trm. In Aim #1, we
will test the hypothesis that Tim3 promotes antigen cross presentation by DC and DC-mediated activation
of naive CD8+ T cells during IAV infection. Specifically, we will (A) identify the intracellular mechanisms
utilized by Tim3 to promote cross presentation, (B) characterize the expression and function of Tim3 on
human lung DC, and (C) determine the role of Tim3 on lung DC in activating naïve CD8+ T cells during IAV
infection. In Aim #2, we will test the hypothesis that Tim3 promotes viral clearance and attenuates immune-
mediated lung injury during IAV infection and promotes IAV-induced CD8+ Trm formation. Experiments in
this aim will A) define the effect of Tim3 in regulating effector CD8+ T cell responses in the lung during IAV
infection and (B) determine the role of Tim3 in IAV-induced CD8+ Trm formation. These experiments are
a critical first step toward developing Tim3 as a therapeutic target for influenza.

Public health relevance
PROJECT NARRATIVE During influenza infection, regulation of anti-viral T cells is necessary to promote clearance of the virus and prevent injury of the lung. Dendritic cells activate anti-viral T cells, and both dendritic cells and T cells express a regulatory protein called Tim3. A better understanding of how Tim3 controls immune cells during influenza could lead to new treatments for this disease and other respiratory viruses.